Towards Genome Engineering: Principles of precision in RNA-binding and cDNA-synthesis for a site-specifically targeted non-LTR retroelement

ABSTRACT
Transposable elements are selfish genes widespread in all domains of life that are capable of moving to
new sites in the genome. Non-long terminal repeat (non-LTR) retroelements, the ancestral and most diverse
eukaryotic retrotransposons and the most prevalent and active transposable elements in the human genome,
are implicated in a number of host cell processes including development, gene expression, cancer progression
and genome evolution. Non-LTR retroelements integrate through a process called target-primed reverse
transcription (TPRT) in which the retroelement protein reverse transcribes the retroelement RNA directly into the
genome. This mechanism bypasses the creation of a double-stranded DNA break and avoids the need for
homologous recombination, providing incentive to thoroughly understand protein and RNA features that facilitate
this process for future gene therapy endeavors. The site-specific R2 non-LTR retroelement has been the primary
model for studying TPRT. The evolutionary persistence of R2 mobility, despite changes in protein and template
RNA sequence, provides an opportunity to elucidate fundamental requirements for, as well as phylogenetic
diversification of, the TPRT mechanism. This work proposes a combination of biochemical, molecular and
cellular approaches to elucidate the principles of the affinity between the R2 retroelement protein and RNA, to
decipher the principles of the very high specificity of their interaction and to achieve complete TPRT-mediated
transgene insertion. This project will build upon my foundation in RNA biology and advance my research career
as I receive rigorous training under Dr. Kathleen Collins, who has expertise in RNA-protein interaction,
ribonucleoprotein complex formation, and reverse transcriptases. This work will contribute to a greater
understanding of how evolution has honed and diversified the pairwise specificity of a retroelement protein and
RNA in addition to furthering the eventual goal of exploiting non-LTR retrotransposons for transgene introduction.

Public health relevance
PROJECT NARRATIVE An overarching goal of gene therapy development is to work towards effective personalized healthcare, which includes the non-toxic integration and expression of therapeutic genes. Non-LTR retroelements offer a promising new avenue in which a transgene could be directly introduced site-specifically into the genome through reverse transcription of a template RNA primed from a nick at the DNA target site. The findings from this proposed work will contribute to the broader understanding of non-LTR protein-RNA interaction specificity and will directly inform future RNA template design in efforts to repurpose retroelements for gene therapy.